Characterization of assembly factors for type IV secretion systems

Abstract
Many bacterial pathogens employ complex, specialized secretion systems to export toxins and deliver
effectors into the cytoplasm of mammalian cells. Although a significant amount of work has been done on
identifying components of these secretion systems, less is known about the factors that are required for
their assembly/function. We propose to identify and characterize these assembly factors by studying the
type IVB secretion system of Legionella pneumophila. This system, called Dot/Icm, is used by L.
pneumophila to survive and replicate within alveoloar macrophages, thereby mediating a pneumonia-like
disease called Legionnaires’ disease. The L. pneumophila T4BSS is encoded by approximately thirty
dot/icm genes. These genes are essential for intracellular replication and virulence of this pathogen, but
most are not required for growth of the organism on media. However, dotL is an essential gene under all
conditions and a large number of suppressors can be isolated that allow a ∆dotL strain to live. These
suppressors include mutations in other dot/icm genes and in a number of putative assembly factors
including DjlA and LdsA. Based on these observations, we propose to isolate additional ∆dotL lethality
suppressors using Tn-seq and to elucidate how DjlA and LdsA function in the assembly/function of the
Dot/Icm T4BSS. Information acquired will provide insight into how L. pneumophila’s T4BSS assembles
and functions and may reveal novel targets for drug intervention.

Public health relevance
Project narrative: This proposal outlines a plan to identify and characterize assembly factors for the Legionella pneumophila Dot/Icm type IVB secretion system (T4BSS). Acquired information will provide important information for future therapeutic approaches to treating bacterial infections.